Multi-center observational study of the relationship of ventilation and outcomes from cardiac arrest using existing data

Project Summary/Abstract
Introduction: Out-of-hospital cardiac arrest (OHCA) is a major public health problem that affects over 350,000
adults in the United States each year. Survival from OHCA remains unacceptably low despite promising
advances over the last decade. During cardiac arrest, all circulation stops. Quickly restoring circulation and
oxygenation to vital organs such as the heart and brain are important goals of out of hospital cardiac arrest
(OHCA) resuscitation. Cardiopulmonary resuscitation (CPR) combines chest compressions with lung inflation
to restore perfusion and oxygenation to the body. During the past decade, research focused on measuring
chest compressions during CPR has lead to improvements in performance of chest compressions and
increased survival rates. However, ventilation has long been a “neglected parameter” in CPR research, in
part, because measuring ventilation during OHCA and CPR is difficult. To address this problem, we developed
a novel method for measuring ventilation during CPR using thoracic bioimpedance (electrical resistance),
which can be monitored through defibrillator pads placed during CPR. Using data from the Resuscitation
Outcomes Consortium Dallas-Fort Worth site, we showed that good quality ventilation is associated with
improved outcomes such as survival to hospital discharge. However, a multi-center study is necessary to
establish the generalizability of those findings.
Objectives: To measure ventilation metrics and to determine the association of ventilation during standard
CPR with outcomes such as survival to hospital discharge and survival with favorable neurological outcome in
patients suffering OHCA.
Methods: The study will use data from one of the largest, comprehensive OHCA multi-center trial in the world.
The ROC Continuous Chest Compression (CCC) Trial database includes CPR resuscitation metrics, patient
outcomes, and access to defibrillator bioimpedance recordings, a rare combination for a cardiac arrest
database. A validated method to identify acceptable bioimpedance ventilation waveforms has been
programmed into an automated computer algorithm, which will extract ventilation data from defibrillator
recordings from approximately 4,000 patients from six ROC sites that participated in the CCC Trial. Ventilation
data will be matched with clinical data for each case.
Specific Aims: 1) To determine ventilation frequency, incidence, tidal volume, and inspiratory and expiratory
times from the 30:2 CPR defibrillator files of six participating ROC regional clinical sites. 2) To determine if
ventilation frequency, incidence, and fraction during ventilation with a bag-mask device is associated with
survival outcomes in the 30:2 CPR group. 3) Compare outcomes of the 30:2 vs. CCC groups of the CCC Trial.
Significance: The results may provide evidence for a paradigm shift and impact CPR training, guidelines, and
the future delivery of resuscitation care to hundreds of thousands of people annually in the United States.

Public health relevance
PROJECT NARRATIVE This research will use a novel approach to measure ventilation from defibrillator files recorded during CPR in approximately four thousand patients in a multi- center clinical trial. A study in one site of the Resuscitation Outcomes Consortium showed that ventilation is associated with improved patient outcomes. The proposed multi-center study will provide generalizable evidence to establish the importance of ventilation during CPR that could lead to a paradigm shift in CPR training, guidelines, and the delivery of resuscitation care to hundreds of thousands of people annually in the United States.